New Mexico Occupational Health Surveillance Program

Project Summary
The New Mexico Occupational Health Surveillance Program (NMOHSP) has been in existence
for over 17 years. The program collects, compiles and analyzes data from many sources and
uses them to identify and address areas of concern for worker safety and health. NMOHSP was
instrumental in the addition of occupational illnesses and injury to the list of notifiable conditions
in the state of New Mexico. NMOHSP collects, generates and interprets 24 Occupational Health
Indicators, receives and analyzes workers' compensation and hospital discharge data, and has
ensured that industry and occupation questions are a part of the state's Behavioral Risk Factor
Surveillance System every year. NMOHSP staff carry out in-depth case investigations for
occupational exposure to toxins reported to New Mexico Poison and Drug Information Center,
elevated blood lead levels in adults, and deaths or injuries in the workplace reported in the
media. Since the beginning of the COVID-19 pandemic, NMOHSP has aided the Infectious
Disease Epidemiology Bureau (IDEB) with the collection and analysis of occupational data on
COVID-19 cases, and the New Mexico Occupational Health and Safety Administration (NM
OSHA) in identifying workplaces with multiple COVID-19 cases to allow for quick intervention. In
the current Fundamental Plus application, NMOHSP proposes to continue fundamental
activities with a specific focus on standardizing protocols and providing clear documentation and
planning that will allow the program to increase capacity and effectiveness. NMOHSP has a
growing role and impact and meeting full potential can best be achieved with careful planning,
organization and evaluation. In addition, NMOHSP will analyze the COVID-19 case data on
occupational and industry and use the findings to release a public report, including a priority list
of industries and occupations who appear to be at elevated risk. In close partnership with NM
OSHA, this report will be used to develop industry/occupation specific guidance on prevention of
respiratory infectious disease spread in the workplace. This guidance is greatly needed, not only
for current COVID-19 efforts, but for future pandemics, and even to decrease the impact of
seasonal influenza. Lastly, NMOHSP will work with the New Mexico Department of Health's
Office of the Tribal Liaison on a comprehensive long-term plan for effective communication and
partnership with the state's indigenous sovereign nations.

Public health relevance
Project Narrative Occupational injuries and illnesses pose a substantial burden on communities, both financially and in terms of quality of life and mortality. Alleviating this burden requires an understanding of the nature, causes, victims and impacts of these injuries and illnesses. This understanding is achieved via occupational health surveillance activities, and can then be leveraged to effect positive change.